Bioassay Guided Isolation of Hypoglycemic Compounds from Philippine Medicinal Pla

Program Director/Principal Investigator (Last, First, Middle): Tolosa, Leah Project Description The Philippines is one of the planet's biodiversity hot spots. Of 6,000 endemic plants, it is believed that traditional doctors and herbalists use about 1,500 as medicinal plants of which only 1% has been characterized for their active components. Despite this paucity of information, in developing countries such as the Philippines where drugs imported from the developing world are beyond the purchasing power of the majority, herbal medicines remain as the main source of remedies for many ailments. Thus, the long-term objectives of this study is to definitively identify plants that are anti-diabetic based on bioassays for metabolite levels, as well as provide a novel method of quantifying efficacy of herbal medicines based on bioassay guided responses of experimental animals. The former will have an immediate impact in the availability of effective and affordable remedies for diabetes in the Philippines. The latter will provide a means of fact-based quality control of herbal medicines that at present is not always available even in the US. In order to arrive at these objectives, we propose to screen 10+ indigenous plants that have been reported to possess anti-diabetic properties. Screening will be executed at the University of the Philippines Diliman. The screening of crude extracts, fractions and isolates will be bioassay directed using a set of biosensors for glucose, glutamine and fatty acids. These biosensors are currently being developed in the Tolosa lab under project grant R01DK072465 for a device for continuous metabolite monitoring. Although the final device is not yet ready, the individual protein- based sensors can be used in an assay format to test for metabolites in blood. Thus, we propose to develop the protocols for measuring metabolite levels in Male Swiss Webster mice in response to a high glucose load. Using this bioassay protocol, we will screen and identify two plants with the most potent hypoglycemic activity from identified Philippine medicinal plants that have been folklorically reported for the treatment of diabetes. Crude extracts will be successively fractionated until the hypoglycemic constituents(s) are isolated from the two most potent Philippine medicinal plants. The chemical structures of these pure compounds will be determined by standard spectroscopic techniques. The novelty of this project is that rather than measuring a single metabolite (glucose), we will multiplex glucose, glutamine and fatty acids to see ratios and trends of these metabolites in response to a high glucose load, and then to the anti-diabetic principle(s). It should be interesting to see if patterns can be gleaned from these trends to further classify anti-diabetic compounds into groups based on their activity. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Tolosa, Leah Project Narrative The geography of the Philippine archipelago makes it one of few places on earth with a rich diversity of terrestrial and marine species, many of which have yet to be discovered or characterized. Because of this, Filipinos have a very long history of employing many natural products for various uses including for medicinal purposes. As pharmaceuticals imported from developed countries become more expensive and beyond the purchasing capacity of most Filipinos, fact-based determination of efficacy of readily available herbal medicines is an imperative. Here we propose to screen several Philippine indigenous plants used in traditional Filipino medicine for the treatment of diabetes and its symptoms. These plants will be screened based on their capacity to lower blood glucose levels and affect two other metabolites, glutamine and fatty acids. At the end of the project, we hope to isolate, purify and identify the active principle(s) in the two most active plant species. An immediate impact of this study is the definitive identification of plants that can be readily availed by Filipinos in preventative or maintenance care of diabetes. On the long term, identification of the chemical structures of the active components of these plants will provide lead compounds for further drug development. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page